STRESS, COPING AND PERSONALITY IN AGING MEN AND WOMEN

Previous research in this Laboratory and elsewhere has shown that in American samples, mean levels of some personality traits decline while others increase during the decade of the 20s. To investigate the cross-cultural generalizability of this adult developmental sequence, the NEO-PI-R was translated into Korean, Croatian, and Italian, and data were collected from college students and adults. The same pattern of age differences was found in each culture and in both sexes, suggesting this may be a universal maturational phenomenon. Longitudinal research on personality, stress and coping will continue.